Chronic kidney disease of unknown etiology: applying a multidisciplinary approach to investigate the world's most common tubulointerstitial kidney disease

PROJECT SUMMARY
The proposed diversity supplement supports post-doctoral research training for Dr. Marimar Contreras-Nieves,
MD, MS candidate. Dr. Contreras-Nieves aims to develop an academic research career in nephrology, with a
focus on studying environmental risk factors for kidney disease. As the top graduate of her medical school
class at the University of Puerto Rico, Dr. Contreras-Nieves enhances diversity in the nephrology workforce
because: 1) women from her background are underrepresented in medicine, 2) as a fluent Spanish speaker,
she is able to provide culturally concordant care to persons facing language and sociopolitical barriers to health
care, and 3) her research interests focus on underserved and rural populations. The goal of this research
supplement will be to provide Dr. Contreras-Nieves practical experience in field research in her topic of
interest: kidney disease in agricultural workers. In the process of implementing this project, she will be gaining
experience in environmental epidemiology, study design, cross-sectional and longitudinal analyses, and
primary data collection. Her multidisciplinary team of mentors will include as primary mentor nephrologist Dr.
Shuchi Anand, Associate Professor of Medicine, Stanford University, geochemist Dr. Penny Vlahos, Professor
of Marine Sciences at University of Connecticut, and statistician Dr. Maria Montez-Rath, Director of the
Biostatistics Core of the Division of Nephrology at Stanford University. Dr. Contreras-Nieves participation will in
turn lead to manuscripts focused on persons with rapid kidney function decline within the cohort recruited
under Dr. Anand’s R01 and generate new knowledge to facilitate ongoing research in the field of chronic
kidney disease of uncertain etiology.

Public health relevance
PROJECT NARRATIVE With assistance from this diversity supplement to R01DK127138 (PI: Anand), Dr. Marimar Contreras-Nieves MD, MS candidate will obtain hands-on research training in her field of interest, kidney disease among agricultural workers. She will work with a field team based in Sri Lanka, statisticians based at Stanford, and geochemist based at the University of Connecticut to evaluate the trajectory of persons with rapid kidney function decline within the cohort recruited under the aims of the parent grant. The project will equip her with field team management and statistical analysis skills, and thereby facilitate her progress to an independent academic career in nephrology.